Mechanism for arsenic induced carcinogenesis

Abstract Chromosomal instability (CIN) contributes to carcinogenesis by promoting aneuploidy. Arsenic is well known to induce aneuploidy, however the molecular mechanism by which arsenic induces aneuploidy-mediated carcinogenesis is yet to be delineated. We have identified a miRNA (hsa-miR-186) that is overexpressed in arsenic-induced squamous cell carcinoma and that induces CIN when overexpressed in human keratinocytes. This miRNA is encoded within intron 9 of the ZRANB2 gene and is co-transcribed as part of the ZRANB2 transcript. Such embedded microRNAs are processed out of the intronic RNA by the microRNA maturation machinery. ZRANB2 encodes an alternative splicing factor containing two zinc fingers each with four-cysteines coordinating the zinc. These types of zinc fingers are targets for arsenite displacement of zinc. We hypothesize that chronic arsenic exposure disrupts ZRANB2 function by displacing zinc from the zinc fingers; cellular homeostatic mechanisms induce ZRANB2 transcription; coincident increased hsa-miR-186 leads to CIN contributing to arsenic-induced carcinogenesis. This project will determine the role of hsa-miR-186 in arsenic induced CIN in human keratinocytes, and how ZRANB2 structure and function are modulated by arsenic exposure. The following specific aims will be pursued to test this hypothesis: 1. Determine role of hsa-miR-186 in carcinogenic transformation of immortalized keratinocytes (HaCaT cells).; 2. Determine mechanism of arsenite disruption of ZRANB2 structure and function; 3. Determine potential of hsa-miR-186 over-expression to induce chromosomal instability and potential of arsenite to inhibit ZRANB2 directed splicing in primary keratinocytes. Successful completion of these aims will demonstrate a novel mechanism for epigenetic response to the environmental stress of arsenic exposure and demonstrate that this response causes chromosomal instability (CIN) linked to arsenic-induced skin carcinogenesis. This mechanism likely plays a role in arsenic-induced carcinogenesis in other organs as well. Thus, hsa-miR-186 could be a biomarker for arsenic induced internal cancers in arsenic exposed patients. Demonstration of arsenite-exposure disturbance of mRNA splicing patterns will open a new area of research into mechanisms of arsenic induced disease.

Public health relevance
Narrative Arsenic exposure via drinking water is a world-wide health problem. Skin is the major target organ of arsenic and skin cancer is a common outcome of chronic arsenic exposure. This application proposes to investigate a novel mechanism of arsenic-induced skin cancer.